Reovirus Neuropathogenesis

Viral encephalitis is an important cause of morbidity and mortality in children and adults. Key knowledge gaps
about the pathogenesis of viral encephalitis include how neurotropic viruses target the central nervous system
(CNS), internalize into neurons, and disseminate in the brain. The proposed research uses reovirus, a
genetically tractable double-stranded RNA virus that causes encephalitis and shows promise as an oncolytic
agent, to dissect mechanisms of viral tropism, cell entry, and spread in the CNS. Reovirus strains display
serotype-specific patterns of systemic dissemination and neurologic disease. Serotype 3 (T3) reoviruses are
exquisitely neurotropic, internalize into neurons using macropinocytosis, and spread intracellularly by fast
axonal transport. Reovirus uses β1 integrin to internalize into some types of cells, but its function in neural cell
entry is unknown. Other previously identified reovirus receptors are dispensable for reovirus infection in the
murine CNS. We recently identified a new reovirus receptor, paired immunoglobulin-like receptor B (PirB), that
allows serotype-independent reovirus infection of cultured cells but is required for efficient T3 infection of
neurons and full neurovirulence. Three integrated specific aims are proposed to enhance knowledge of reovirus
neuropathogenesis that may have broader applications to other neurotropic viruses. In Specific Aim 1,
functions of host receptors in reovirus neuropathogenesis will be determined. Biophysical interactions between
PirB and reovirus will be assessed using cryo-electron microscopy, atomic-force microscopy, and structure-
guided mutagenesis. The function of PirB in reovirus disease will be elucidated by comparing infection and
virulence in wild-type (WT) and PirB-null mice. T3 reovirus-specific receptors that couple with PirB for
neurotropism will be identified using CRISPR activation screening. In Specific Aim 2, mechanisms of reovirus
entry into CNS neurons will be defined. The functions of PirB and β1 integrin in reovirus neural entry will be
determined using mutant receptors and receptor-blind viruses. Receptor-dependent control of macropinocytosis
will be elucidated using super-resolution, live-cell, and electron microscopy. Mechanisms of dynein motor
recruitment for reovirus transport within axons will be dissected by investigating interactions between WT and
mutant reovirus receptors and dynein subunits. In Specific Aim 3, the basis of reovirus dissemination in the
CNS will be elucidated. The role of host receptors in reovirus neural transit will be defined using whole-brain
imaging and three-dimensional reconstruction to trace reovirus infection and neural spread in WT and receptor-
null mice. Mechanisms of reovirus transsynaptic transmission will be elucidated using in vitro and in vivo neural
circuits. The effect of altering synaptic activity on reovirus neural transit will be tested using pharmacologic
intervention and chemogenetically altered mice. Taken together, these studies will define mechanisms used by
neurotropic reovirus to infect and disseminate in the brain and may promote further development of reovirus
oncolytics that selectively target the nervous system.

Public health relevance
The proposed research will enable a better understanding of mechanisms used by viruses to infect specific CNS regions and spread within neurons to disseminate in the brain. This information will be useful for the identification of new drug targets for the treatment of viral encephalitis and the development of precision-guided oncolytic vectors to treat nervous system cancers.